A Novel Broad-Spectrum Nanoimmunotherapeutic Approach for Combating Multidrug Resistant Bacteria

PROJECT SUMMARY
Multidrug-resistant (MDR) bacterial infections have emerged as an urgent global public health threat. The
ESKAPE pathogens, comprising six virulent MDR bacteria, are major contributors to life-threatening nosocomial
infections. Traditional antibiotic therapies are becoming increasingly ineffective due to the emergence of
antibiotic resistance and the stagnation of new antibiotic development. Therefore, there is an urgent need for
innovative non-antibiotic antimicrobial approaches to combat these MDR pathogens. To meet this urgent need,
we developed an innovative nanoimmunotherapy mediated by a novel red blood cell membrane (RBCM)-coated
hemoglobin (Hb)-encapsulating nanoparticle saturated with oxygen (termed RHNP). RHNP functions by
sensitizing bacteria to host oxidant killing while simultaneously recruiting neutrophils and enhancing their oxidant
killing capability. Our preliminary studies have shown that this approach was highly effective in treating antibiotic-
resistant bacterial infections in several mouse models. The objective of this project is to further develop RHNP
to achieve broad-spectrum antimicrobial capability against Gram-negative MDR ESKAPE bacterial pathogens,
including carbapenem-resistant Acinetobacter baumannii (CRAB), carbapenem-resistant Klebsiella pneumoniae
(CRKP), and MDR Pseudomonas aeruginosa (MDRPA). We hypothesize that (1) RHNP can offer a broad-
spectrum non-antibiotic immunotherapeutic approach for combating MDR bacteria, and (2) RHNP can exhibit
synergistic effects with conventional antibiotics. In Aim 1, we will design, fabricate, characterize, and optimize
the RHNP. We will optimize the RHNP formulation (i.e., Hb-cholesterol (Chol)@RBCM NP) by optimizing the
ratios of Hb/Chol and RBCM/Hb-Chol. RHNPs will be fabricated via both a batch and a continuous process.
RHNPs with desirable physiochemical characteristics and biocompatibility will be identified for studies described
in Aims 2 and 3. In Aim 2, we will first examine the antimicrobial efficacy and mechanisms of RHNP in treating
the MDR planktonic bacteria. We will then study the synergistic effects and synergistic mechanisms of
RHNP/antibiotic combination therapy against MDR planktonic bacteria. Subsequently, the antimicrobial efficacy
of RHNP with or without antibiotics against bacterial biofilms will be investigated. In Aim 3, we will study the
therapeutic efficacy of RHNP alone or in combination with antibiotics in three rodent infection models
representing different healthcare-associated infections. The effects of neutrophils and macrophages on the
therapeutic outcome will also be assessed to further clarify the immunotherapeutic mechanisms. The safety of
RHNP will be evaluated by hematological and biochemical parameters, inflammatory cytokines, and organ
histopathology in mice. RHNP represents a transformative approach to treating MDR infections, offering a
universal, safe, and effective immunotherapy option. Its potential to enhance the effectiveness of existing
antibiotics could also transform current antibiotic treatment protocols. This project has the potential to save
countless lives and will significantly alleviate the burden on healthcare systems worldwide.

Public health relevance
PROJECT NARRATIVE Decades of antibiotic overuse and misuse have led to the rise of multidrug-resistant (MDR) bacterial pathogens, resulting in over 2.8 million antibiotic-resistant infections and more than 35,000 deaths annually in the U.S. alone. To address this public health crisis, we aim to develop a new class of broad-spectrum nanoimmunotherapeutics that not only sensitize bacteria to host oxidant killing, but also enhance the activity of host oxidant killing. This innovative approach promises a universal, safe, and effective solution to combat MDR bacterial infections and potentially offers synergistic effects with existing antibiotics.